C. officinalis induction of Nrf2 inhibiting type 1 diabetes

7. Project Summary/Abstract
Type 1 diabetes (T1D) is an autoimmune disease initiated by genetic predisposition and environmental
influences culminating in the destruction of pancreatic β-cells with irreversible loss of insulin production. Despite
strong predictive biomarkers of T1D, there is no cure and only one recently approved interventional therapy with
moderate effects. Therefore, identification and development of novel T1D interventional therapeutics are needed
and explored in this proposal. A potential source for novel interventional therapies is from the frequently used
Cornus officinalis (CO) in the field of ethnopharmacology.
We have recently shown that CO could inhibit cytokine mediated pancreatic β-cell death, promote cell
viability/oxidative capacity, and increase expression of critical transcription factors necessary for pancreatic β-
cell function (Mol.Cell.Endo.2019:494:110491). Our recent in vitro proteomic examination of CO stimulation of
1.1B4 cells revealed activation of the Keap1/Nrf2 pathway in the 1.1B4 pancreatic β-cell line
(Mol.Cell.Endo.2022:557:111773). Specifically, we have shown that CO induces Nrf2 nuclear translocation along
with increased protein expression of Nrf2-stimulated antioxidant genes such as Glutathione reductase (GR),
Glutamate-cysteine ligase catalytic (GCLC), Heme Oxygenase-1 (HO-1) and Superoxide dismutase 2 (SOD2)
along with others. To determine feasibility of a CO interventional approach in NOD mice, we performed a small-
scale preliminary study examining if oral delivery of CO by gavage could be well tolerated and safely delivered
daily. Ten wk. old female NOD male mice were given CO or water by oral gavage for 14 wks. once daily 5 days
per wk. No detrimental effects were observed and mice in all treatment groups grew to similar sizes. In addition,
diabetic onset, appearance of hyperglycemia (single glucose reading >130 mg/dl) and pancreatic insulitis was
significantly inhibited in the CO treated NOD mice. Based on our findings, we hypothesize that CO can
promote pancreatic β-cell viability via stimulation of the KEAP1/Nrf2 pathway to inhibit the progression
of T1D. The hypothesis will be examined by the following specific aims:
• Aim 1: Determine the effect of CO on T1D pathogenesis in the NOD mouse.
• Aim 2: Measure the impact of CO on the KEAP1/Nrf2 pathway in primary islets.
• Aim 3: Examine if Nrf2 activation is necessary for CO induced biological effects in the NOD.
Our proposal will employ an interdisciplinary approach with combined expertise from an established research
team to address a significant need for T1D treatment. The overall experimental design is innovative and will
utilize state of the art proteomic technology in combination with in-vivo and in-vitro methods to reveal the
pharmacological action of CO to serve as a novel supplemental interventional preventative treatment of T1D to
promote β-cell survival and delay clinical progression.

Public health relevance
8. Project Narrative Type 1 diabetes (T1D) is an autoimmune disease of increasing incidence resulting in the loss of pancreatic β- cells and lifelong dependency on exogenous insulin with only one recently approved preventative measure to marginally delay onset. Our preliminary evidence indicates Cornus officinalis (CO), an herbal medicine, can promote pancreatic β-cell survival via promotion of Nrf2 and autophagy, stimulate antioxidant pathways and inhibit onset of T1D in the non-obese diabetic (NOD) mouse. Therefore, this proposal aims to determine clinical efficacy in-vivo by elucidating the biological mechanism of CO to be utilized as a therapeutic option for T1D interventional therapy.